Dissecting the role of gut microbiome dysbiosis in lung cancer development and progression.

PROJECT SUMMARY
Lung adenocarcinoma (LUAD) is the most common type of non-small cell lung cancer (NSCLC) and is, for the
most part, causally related to tobacco exposure. Despite recent advances in treatment (e.g., immunotherapy),
LUAD patients still often display poor prognosis in part due to inferior therapeutic responses and late diagnosis.
There is a pressing need for effective strategies to prevent or treat early-stage LUAD in high-risk individuals such
as lifetime smokers. Accumulating evidence has shown that microorganisms in the gut can shape overall
immunity and influence states of health and disease, including cancer at the systemic level. Yet, we still do not
fully understand the role of the gut and host microbiome in development of LUAD, the most common type of
malignancy outside the gastrointestinal tract. We previously showed that gut microbiome changes are strongly
associated with development of LUAD in a human-relevant, tobacco-associated mouse model (Gprc5a-/-; G). On
top of this, knockout of Lcn2, an antimicrobial protein, in these mice (Gprc5a-/-/Lcn2-/-; GL) reduced microbial
diversity while enhancing inflammation, including expression of various pro-inflammatory cytokines such as IL-
6, and lung tumor development. These earlier and preliminary findings motivate my hypothesis that gut microbial
dysbiosis (such as that incurred by Lcn2 loss) can stimulate a systemic inflammatory cascade conducive to tumor
growth via an IL-6-dependent pathway. I will address this hypothesis through two aims. Aim 1 will determine how
gut dysbiosis impacts immunomodulation and inflammation during LUAD development. Using genetic deletion
(global and immune-subset specific) and pharmacological inhibition strategies, I will dissect the role of the IL-
6/STAT3 pathway downstream of gut microbiome dysbiosis in LUAD pathogenesis and immune responses. Aim
2 will interrogate the preventive and early therapeutic roles of specific bacterial taxa, alone or in combination with
anti-inflammatory agents, in mitigating LUAD pathogenesis. Specifically, I will examine the effects of
Limosilactobacillus reuteri treatment in tobacco carcinogen-exposed animals on LUAD pathogenesis, including
in combination with strategies targeting IL-6/STAT3 signaling. Leveraging human-relevant mouse models and
cutting-edge immune profiling techniques, I aim to unravel the intricate interplay between gut dysbiosis,
inflammation, and LUAD development, paving the way for innovative prevention and early intervention strategies.
This research endeavor not only seeks to deepen our understanding of host mechanisms governing LUAD
progression but also pave way for development of novel avenues for prevention and treatment, potentially
incorporating probiotic interventions. By targeting high-risk individuals, such as smokers, with tailored
approaches, we aspire to alleviate the burden of LUAD and improve outcomes for affected individuals.

Public health relevance
PROJECT NARRATIVE This research aims to uncover how the gut microbiome influences inflammation, tumor immunity, and the development of lung adenocarcinoma (LUAD). Additionally, it seeks to identify effective combinatorial treatments for LUAD consisting of microbiome-based interventions and approaches targeting pro-inflammatory signaling. At its conclusion, the proposed work will pave way for new strategies to prevent, intercept, or treat early-stage LUAD in high-risk individuals such as heavy smokers, thus, lessening the overwhelming public health burden of this ominous cancer.